Optimizing Individualized and Adaptive mHealth Interventions via Control Systems Engineering Methods

Project Summary/Abstract. Although previous research has identified the importance of a human-centered
design approach to the development of digital behavior change interventions (DBCIs) which considers the
digital literacy and health status of the target population, current commercially available mHealth applications
do not meet the language, prerequisite knowledge, incentive, and unique cultural needs of Hispanic/Latinos3-7.
Furthermore, simply taking the protocol of English language, higher digital literacy DBCIs, and translating the
material to match the user’s preferred language has not been found to positively influence DBCI app usage or
engagment7. The parent R01 is being conducted in Greater San Diego, where the population is estimated to
be 34% Hispanic/Latino, and targets enrollment to recruit a representative sample of this region16. Therefore,
the parent grant provides an excellent opportunity to study the implementation of, and engagement with, a PA
focused DBCI among a diverse sample population including a significant group of Hispanic/Latino participants.
This study will use a multimethod approach (qualitative and quantitative) to provide an in-depth understanding
of the unique factors related to DBCI engagement among Hispanic/Latinos. These results will directly inform
the design and optimization of the next generation of culturally relevant and engaging DBCIs based on the
control optimization trial (COT) approach to developing personalized and perpetually adapting interventions.
This diversity supplement will support Mr. De La Torre in developing a culturally adapted version of the
YourMove intervention, specific for Hispanic/Latino families. This target produces multiple synergistic benefits
including: 1) for Mr. De La Torre, the proposed work would be excellent for enabling him to apply for a possible
K-award from the NIH, to support his transition into becoming a faculty member committed to developing
DBCIs that specifically serve Hispanic/Latino populations in his career and to advance health equity, 2) for
Hispanic/Latino communities, the diversity supplement will enable the rigorous cultural tailoring, through the
supplements aims, and 3) for the parent R01, this diversity supplement will enable the methods and
approaches to be used and refined, with a specific focus on reducing health inequities and disparities; thus, the
diversity supplement provides a mechanism for the parent R01 to contribute more meaningfully to advancing
health equity, by providing a concrete, actionable pathway for developing a translated and culturally
appropriate extension of the YourMove intervention. The activities proposed in this supplement remain within
the original scope of the parent award and will increase the impact of the knowledge gained from the parent
study, particularly for Hispanic/Latino study participants.

Public health relevance
Project narrative. The research goals and training objectives in this supplement build upon the unique strengths and opportunities afforded by the parent grant to support transitioning Mr. De La Torre into his next career stage and aid in the development of culturally relevant digital behavior change interventions (DBCIs).